Core B: Preclinical Models Core

PROJECT SUMMARY / ABSTRACT: PCMC
The PCMC will serve as a central repository for generation, propagation, and characterization of patient-derived
organoids (PDOs) from both normal and colorectal cancer (CRC) tissue, as well as isolation of innate immune
and participant-matched cytotoxic CD8+ T cells. The PCMC will provide technical expertise to conduct key
experiments using these resources. The PCMC will provide support to all three projects within this GI
SPORE application and interact closely with the Tissue Pathology and Cellular Analysis Core (TPCA)
and the Biostatistics and Bioinformatics Core (BBC).
The PCMC is established to support this GI SPORE application in developing and testing novel therapeutic
strategies to treat CRC using physiologically relevant complex PDO models. The PCMC will utilize its extensive
expertise in PDO methodologies to establish and characterize complex models that recapitulate various aspects
of CRC tumors and their microenvironment that includes stromal and immune cells. The overarching goal will be
to validate molecular targets of therapeutic strategies developed by the Projects in a preclinical setting using
PDOs that include relevant fibroblast and immune cell types. The PCMC will coordinate efforts, consolidate
resources, and share experimental expertise by pursuing three Specific Tasks: 1) Generate, maintain, and
characterize the CRC PDO biobank; 2) Provide expertise and resources to generate or establish epithelial-only
PDO cultures as well as additional complex models, including air-liquid-interface (ALI) cultures and PDOs
derived by fine-needle-aspiration (FNA), which self-organize in vitro with multiple stromal/immune cell types; and
3) Provide technical expertise for differentiating colonic PDO models.
The immediate goal of the PCMC is to provide support to all three of our projects and the TPCA and BBC. Core
personnel will work closely with project and other core leaders to ensure effective support and two-way
communication. The longer-term goal of the PCMC is the wider dissemination of these resources and expertise
to provide relevant preclinical models that serve as a precision-medicine platform for treatment of CRC patients.